Health-professional Education Partnership Initiative - Transforming Ugandan Institutions Training Against HIV/AIDS (HEPI-TUITAH)

Abstract
Uganda is one of the 10 countries that, together, account for 81% of the estimated 24.7 million people
living with HIV (PLWH) in Sub-Saharan Africa (SSA). The most recent surveillance data (2016) show an HIV
prevalence of 6.5% in the general population in Uganda (1.4 million PLHIV), and this burden is
disproportionately born by women (7.6% seroprevalence) vs. adult men (4.7%). Although HIV prevalence in
rural Uganda is somewhat lower (5.8%), this is where 80% of the population resides; yet, 71% of doctors and
41% nurses and midwives serve urban areas. Thus, although the majority of PLWH are in rural areas, these
communities are underserved – often with widely scattered healthcare facilities – and need strategic
approaches to attract and retain a well-trained workforce to confront the healthcare and prevention challenges
of the epidemic. The Ugandan National HIV/AIDS Strategic Plan 2016-2020 prioritizes human resources for
delivery of health, prevention, and community-based HIV/AIDS services in both public and non-public sectors.
To address the health-professional training that will be critical to lessening the HIV/AIDS burden –
particularly in rural Uganda – the Mbarara University of Science and Technology (MUST) in rural southwest
Uganda and its partner institutions in rural Uganda (Bishop Stuart, Busitema and Lira Universities) and the US
(Massachusetts General Hospital) propose the HEPI-TUITAH (Transforming Ugandan Institutions Training
Against HIV/AIDS) program. This inter-professional HIV/AIDS service-improvement training program will build
on our successes in the MEPI-MESAU consortium and our current Mbarara University Research Training
Initiative (MURTI; D43TW010128, PI: Obua) and Mbarara University Research Ethics Education Program
(MUREEP; R25TW010507, PI: Kiwanuka) to address the following specific aims: (1) To increase the
competency of undergraduate medical, nursing, midwifery, and allied health professional students in the
management of HIV/AIDS through the "low dose, high frequency" training model for quality clinical education,
patient care, and HIV prevention services in Uganda; (2) To enhance the capacity of primary health care
providers to provide comprehensive HIV services and strengthen bidirectional linkages between health
facilities and communities in rural Uganda; (3) To develop the capacity of undergraduate health professional
students in rural Uganda to conduct locally relevant biomedical, behavioral, clinical, and operations research in
HIV and its co-morbidities; and (4) To strengthen a network of health professional training institutions (HPTIs)
by building a community of practice and leveraging local resources and expertise to mitigate the national
HIV/AIDS burden. At the completion of the TUITAH, we expect to have trained 2,368 health professionals
students and up to 240 Primary Care Providers in HIV/AIDS prevention, care, and research, thus contributing
significantly to the cadre of health professionals serving rural Uganda. The TUITAH program has the potential
to be a model for health provider training throughout SSA.

Public health relevance
Narrative Education in HIV/AIDS care and service delivery at MUST and its partner training institutions will provide undergraduate health professional students and primary healthcare providers with clinical skills and research capacity that will contribute to reduction of HIV/AIDS burden in Uganda. The program is significant in its focus on increasing health services delivery and research in rural Uganda and inclusion of nurses and midwives, given the disproportionate burden of HIV/AIDS borne by women in Sub-Saharan Africa.